Administrative Core

PROJECT SUMMARY
The Administrative Core will be responsible for overseeing the daily functions of the programs in fulfilling the
goal of this Program Project grant. The Core will provide administrative support, including support for grants and
financial management; scheduling of meetings and seminars; coordination of activities between this P01 and
UCLA academic and administrative bodies, and Cedars Sinai Medical Center. The Core will also provide
biostatistical support for all research projects and the management of research data and shared data function of
the program. It will have the responsibility of managing details of the budget, appropriately filing budgetary
information, and will file progress reports and communicate with NCI. The scheduling, dissemination of
information, and organization of the program project Symposium, including the participation of the External
Advisory Board, and oversight of all the established policies for recruitment of women and minorities, and
interaction with other NCI programs will also be the responsibilities of the Administrative Core. The Administrative
Core is under the direction of Drs. Vay Liang W. Go and Guido Eibl with Dr. Gang Li providing biostatistical
support as a Sub-Core Leader. The research projects are: Project 1 investigates adipose tissue inflammation in
obesity-promoted pancreatic cancer; Project 2 explores chemoprevention of pancreatic cancer with lipid
lowering and antidiabetic agents, Project 3 will examine the role of the pancreatic fibroinflammatory
microenvironment in obesity-promoted pancreatic cancer. All projects are integrated, synergistic and utilize an
Administrative Core and a Shared Resource Core, the Animal and Cell Model (ACM) Core (Core 1). The
projects will also utilize the shared cores at the UCLA Agi Hirshberg Center for Pancreatic Diseases, NIDDK
supported Digestive Disease Research Center, NIAAA funded Southern California Center for Alcohol Liver and
Pancreatic Disease, UCLA Clinical and Translational Science Institute (CTSI), and other UCLA shared core
resources in fulfilling the Program Project's goal in chemoprevention and mechanisms of obesity-promoted
pancreatic adenocarcinoma. These facilities are detailed in the Facilities and Resource Page.